Controlled focal drug delivery by endovascular bioresorbable composite implants

Project Summary/Abstract
Focal disease processes affect a specific organ, or part of an organ. Examples include primary
tumors, inflammatory bowel disease, focal epilepsy, post-surgical pain, embolisms. The
mainstay of medical management of these disease processes is drug treatment. However, the
vast majority of our drug treatments of focal disease processes lack spatial targeting. For
example, oral or intravenous drug treatments will deliver drug to the affected region; however,
they will also expose all other organs to therapeutic drug levels. This systemic, off-target drug
exposure causes severe, lethal side effects which limits our use of these medications in treating
disease. To limit off-target side effects, there is significant interest in developing spatially
targeted, focal drug delivery technologies. While some technologies have had important clinical
impact, focal drug delivery has not yet achieved widespread success. We have developed intra-
arterial drug-eluting bioresorbable composite implants that can reduce off-target drug exposure
by 40-fold. For many drug treatments, this would effectively eliminate off-target side effects. Our
implants are designed according to the four following criteria: (1) maximize drug storage and
elution, (2) minimize disruptions to blood flow, (3) biocompatible for clinical use, and (4)
biodegradable with tunable absorption rate when no longer needed. Moreover, this is a platform
technology for delivery of a wide range of drugs, which can be used to treat an array of disease
processes. Through this award, we intend to demonstrate the platform potential of our
technology, by focally delivering two different drugs to two different organs. Additional analyses
will assess for safety and efficacy of our intervention. If successful, the data obtained from this
award would strongly motivate the next steps of product development for pre-clinical trials.

Public health relevance
Project Narrative Oral and intravenous drug administration lacks spatial targeting, exposing all organs and tissues to high drug concentrations, leading to severe off-target side effects. We have recently achieved proof-of-concept for a focal drug delivery technology using polymer-based intra-arterial implants. This proposal is designed to demonstrate the platform potential of our technology, by focally delivering two different drugs to two different organs.